CORE--IN SITU HYBRIDIZATION LABORATORY

(Adapted from the Applicant's Abstract) The specific aims are to provide rapid screening method for examining spatial expression patterns of differentially expressed genes to be cloned in Project 2; to permit Project 3 to localize the temporal and spatial patterns of expression of selected clones by both whole-mount and paraffin-section in situ hybridization; and to provide high quality and reproducible results for Projects 4, 5, and 6 and to prevent the unnecessary duplication of facilities and efforts among the subprojects that are involved.